Administrative Core

The purpose of the Administrative Core is to manage, organize and coordinate the components of the Program Project. It is essential that Core A and the Sub-projects are coordinated to maximize utilization of mouse colonies, mutagenesis and mating protocols, phenotypic screening, and subsequent mutant characterization. Dr. Eppig, as PI of the Administrative Core, will be responsible for coordinating these efforts. The PI will monitor overall progress of the Program and provide administrative oversight and direction. In Dr. Eppig's absence, Dr. Schimenti will assume responsibility. Day-to-day project activities will be managed by the relevant Pis.